Nanotechnology-based platform for the development of next-generation vaccines against opioid use disorder (OUD)

Project Abstract:
The highly complex OUD and overdose epidemic poses a huge public health and economic burden. Current
FDA-approved pharmacotherapies against OUD and overdose use opioid receptor agonists and antagonists.
These therapies show overall limited efficacy, due to their side effects, suboptimal patient access and
compliance, and liability for abuse and diversion. Vaccines offer a new treatment option that is both alternative
and complementary to existing measures. Preclinical testing demonstrated anti-opioids vaccines as a highly
selective long-lasting treatment and prophylactic strategy that protects against opioid-induced antinociception,
motor activity, respiratory depression, bradycardia, and self-administration in pre-clinical models. Previous
clinical trials of addiction vaccines showed proof of efficacy in those subjects who achieved the highest antibody
(Ab) titers, highlighting the need to design more effective vaccines and understanding the basis for variability in
individual efficacy. Hence, this proposal focuses on developing next-generation nanoparticle-based anti-opioid
vaccines and deciphering molecular and cellular mechanisms underlying their efficacy. Our team developed a
novel lipid polymer hybrid nanoparticles (LPNP) platform, that enhanced the efficacy of conjugate vaccines
against nicotine and oxycodone. Based on these preliminary data, we propose further dissecting the molecular
basis of this increased efficacy and testing how nanovaccines composition, and adjuvant display determine
innate and adaptive immune activation and whether specific cellular and molecular mechanisms underlie vaccine
efficacy against OUD. AIM1 will test the effect of different polymers and adjuvant display methods on efficacy of
nanovaccine against oxycodone. As well as how nanoformulation of conjugate vaccine affect the delivery and
bioavailability of vaccine components. Studies will investigate vaccine efficacy in mice, IgG antibody titer and Ig
subclass and vaccine kinetics in terms of biodistribution, accumulation and localization within spleen and lymph
nodes. AIM2 will elucidate whether different nanovaccine formulations show distinctions in innate and adaptive
immune responses. Studies will dissect innate immunity in vitro activation and in vivo dynamics in response to
vaccination, addressing key cell subsets contributing to efficacy, as well as assess the magnitude of B cell
responses. Results will provide a model vaccine that can be easily adapted to other abused substances. Such
information will guide future vaccine design and the rational selection of the most appropriate formulation for a
given antigen. The proposed mentored studies and this F31 fellowship are invaluable training and
professional development opportunity as I strive to become an independent scientist. This hypothesis-driven
multidisciplinary project encompasses various state-of-art approaches that are prerequisites to excel in
translational research at the interface of immunology, pharmacology and substance abuse. The mentorship of
NIDA-funded experts will ensure the successful completion of the proposed studies and the effective
communication of research findings to the scientific community.

Public health relevance
Project Narrative Vaccines are emerging as novel strategies for treating OUD and preventing fatal overdose. To accelerate the clinical utility of conjugate vaccines, we are developing next-generation anti-opioid vaccines using cutting-edge nanotechnology-based platforms. Exploiting the modular nature of nanoparticle platforms, this proposal focuses on characterizing the molecular and cellular mechanisms underlying vaccine efficacy to provide a blueprint for vaccine development and rational design of most effective formulation to a given antigen.